REDS-IV-P - CENTER FOR TRANSFUSION LABORATORY STUDIES (CTLS) - SARS-CoV-2/COVID-19 STUDIES

This project will focus on key blood safety issues with COVID-19 and further our understanding of SARS-CoV-2 natural history and pathogenesis.